Protein Phosphorylation in Health and Disease

Program Director/Principal Investigator (Last, First, Middle): Tagliabracci, V.S./Yaffe, M.
Protein phosphorylation plays a vital role in cellular communication, regulating cellular state and activity. It is a
dynamic process controlled by kinases and phosphatases, which are precisely regulated in healthy cells but
dysregulated in diseases like diabetes, inflammation, and cancer. The study of protein phosphorylation and its
signaling function is a rapidly advancing field, driving methodological and conceptual advancements and
contributing to therapeutic development. In cancer research, protein kinases are frequently deregulated and
have gained significant attention from the pharmaceutical industry. Many FDA-approved cancer drugs target
kinases, and numerous kinase inhibitors are currently in development. This clinical relevance establishes an
exciting connection with translational science.
To support the advancement of knowledge in this field, we seek funding to enable the attendance of trainees,
junior faculty, and underrepresented groups at the 2024 FASEB Summer Research conference on Protein
phosphorylation in healh and disease. This biennial conference, which began in 1983, serves as a key
interdisciplinary gathering, bringing together scientists with diverse expertise. It focuses specifically on the
biochemical mechanisms and fundamental principles of phosphorylation, setting it apart from other conferences
that focus on signaling networks and systems approaches.
The FASEB meeting has a rich history of announcing breakthroughs and aims to enhance and disseminate
knowledge that can lead to improved therapies targeting abnormal kinase activity and protein phosphorylation
in human diseases. The 2024 FASEB Science Research Conference on Protein phosphorylation in health and
disease will highlight cutting-edge discoveries in the field. By uniting disciplines such as structural biology,
biochemistry, systems biology, chemical biology, protein engineering, and medicine, the conference will foster
the interchange of ideas and stimulate new research directions.
Our objectives include promoting communication, collaboration, and career advancement for diverse scientists
in the field. Ultimately, we aim to advance our understanding of the molecular mechanisms governing vital
biological processes and identify critical targets for the diagnosis, prevention, treatment, and cure of human
diseases.
OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Tagliabracci, V.S.,/Yaffe, M. Narrative Protein phosphorylation, regulated by kinases, impacts growth and diseases like cancer and inflammation. The FASEB Conference on Protein Phosphorylation aims to share groundbreaking findings, support young investigators, and enhance our understanding of vital processes. By fostering collaboration, we strive to advance knowledge in this field, leading to better disease diagnosis, prevention, and treatment. OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page